Voluntary National Retail Food Regulatory Program Standards Joint Food Safety Program Participants: Jersey County Health Department and East Side Health Department

Voluntary National Retail Food Regulatory Program Standards Joint Food Safety Program Participants: Jersey County Health Department and East Side Health District Program Dates: September 2015 – August 2020 Project Abstract Working together, Jersey County Health Department (JCHD) and East Side Health District (ESHD) will move towards conformance with the FDA Voluntary National Retail Food Regulatory Program Standards (VNRFRPS). A training plan will be developed to increase the knowledge and expertise of the food program staff at JCHD and ESHD. This program will follow FDA VNRFRPS conformance standards. By project end, Jersey County Health and East Side Health District food programs will significantly advance conformance with the FDA VNRFRPS. As part of the project the two public health agencies will conduct a Retail Food Risk Factor Study. The study will focus on selected food facilities categorized by type. Known foodborne risk factors will be identified and various strategies to reduce the risk factors will be implemented. The information and techniques gained through this study will increase local health agencies ability to recognize foodborne risk factors and successfully implement a risk control plan.

Public health relevance
Voluntary National Retail Food Regulatory Program Standards Joint Food Safety Program Participants: Jersey County Health Department and East Side Health District Program Dates: September 2015 – August 2020 Project Narrative The project will increase the skills and knowledge of the food regulatory program staff at the local public health level. The goals and objectives included in the project will give them the tools they need to effectively identify and reduce the risk factors that cause foodborne illness. At the end of the project the lessons learned and resources will be shared with other public health agencies to assist them in the transformation from a food inspection system to a food safety management system.